Non-Invasive Femtosecond Laser Glaucoma Surgery Guided by Micron-Resolution OCT

Project Summary / Abstract
The major objective of this proposal is to test the hypothesis that high-precision aqueous humor
(AH) drainage channels, which connect the anterior chamber (AC) to Schlemm's canal (SC), created non-
invasively and ab-interno with micron-resolution OCT (µ-OCT) image guided femtosecond laser
trabeculectomy (IGFLT) will increase AH outflow and lower intraocular pressure (IOP) and therefore may
be used as a non-invasive long lasting surgical treatment for glaucoma. Femtosecond (FS) laser pulses
can be delivered through transparent and translucent tissue to perform high-precision, sub-surface surgical
procedures with no collateral damage to adjacent or superficial tissue. These unique properties of FS laser-
tissue interactions provide a marked advantage over traditional laser procedures for high-precision, sub-surface
treatments. Based on these findings we believe that treatment of the trabecular meshwork (TM) area with FS
laser pulses will provide improvements over traditional laser treatments such as argon laser trabeculoplasty
(ALT) and selective laser trabeculoplasty (SLT). We propose that using FS laser pulses to create high-
precision drainage channels (ab-interno) through the TM and juxtacanicular tissue (JCT) will restore the
normal AH outflow facility of the eye and therefore lower IOP. To reliably create such drainage channels the
exact determination of the location of the TM and SC is required. We propose to develop and use a laboratory
prototype of a µ-OCT image guided FS laser system to ensure the accurate placement of the drainage
channels. Major benefits of IGFLT are: 1) ab-interno, non-invasive procedure without any incisions or wound to
the surface, 2) exact placement of the channels with micron accuracy, 3) accurate control of the AH outflow
increase by creating the required channel cross section, 4) potential longevity due to minimized collateral tissue
damage, 5) surgery can be performed as a quick outpatient procedure, 6) potential repeatability due to small
treatment zone with no damage to adjacent tissue. To test our hypotheses we propose the following Specific
Aims: 1) Develop an optical delivery system which couples a surgical femtosecond laser beam with a near
infrared µ-OCT beam, allowing µ-OCT image guided delivery of FS laser pulses for the creation of high-precision
aqueous humor drainage channels from the anterior chamber to Schlemm's canal. 2) Demonstrate µ-OCT image
guided femtosecond laser trabeculectomy using ab-interno delivery of a near infrared FS laser beam through a
gonioscopic contact lens by creating outflow channels of predetermined geometry which connect the AC to SC
in human cadaver eyes. Evaluate the quality and dimensions of the channels with various imaging techniques.
Create technical requirements for clinical technology development. 3) Evaluate the effect of µ-OCT image guided
FS laser created channels on AH outflow facility in human cadaver eyes using standard perfusion methods.
Optimize treatment protocols for predetermined IOP reduction. Confirm final technology requirements for a
portable clinical prototype planned to be developed and tested in a subsequent future project.

Public health relevance
Project Narrative The major objective of this proposal is to test the hypothesis that high-precision aqueous humor (AH) drainage channels connecting the anterior chamber (AC) to Schlemm's canal (SC) created with micron-resolution OCT (µ-OCT) image guided ab-interno femtosecond laser trabeculectomy (IGFLT) can increase the AH outflow of the eye, lower the intraocular pressure (IOP), and provide a novel, non-invasive, long lasting surgical treatment for glaucoma. Femtosecond (FS) lasers are capable of creating subsurface incisions without any damage to the superficial tissue, providing a unique opportunity to establish a non-invasive, long-lasting glaucoma treatment superior to all existing treatments. Successful completion of the project will provide a laboratory prototype of the µ-OCT image guided FS laser system, proof of concept of the proposed IGFLT procedure in human cadaver eyes, and technology requirements for a future clinical prototype.